Astrocyte Transcriptional Dependencies in Brain Circuits

Project Summary
Over the past twenty years our knowledge of astrocytes has undergone a renaissance highlighted by the
identification of dynamic physiological activities, key roles in circuit function, and diverse molecular properties.
Central to the physiological activities of every cell are transcription factors (TFs), yet roles for TFs in mature
astrocyte function and associated circuits in the brain have remained relatively undefined. Our molecular
studies on astrocyte diversity highlighted the expression of developmental TFs in mature astrocytes, in the
adult brain. Among these TFs are members of the Nuclear Factor I (NFI)- and Sox- family, which play essential
roles in early astrocyte development and continue to be expressed in a vast majority of mature astrocytes
throughout the adult brain. Despite exhibiting universal expression in astrocytes across all regions, we found
that NFIA and Sox9 exhibit region specific roles in mature astrocytes, where hippocampal astrocytes require
NFIA to maintain their functional integrity, while olfactory bulb astrocytes require Sox9.
Our finding that astrocytes exhibit region specific transcriptional dependencies, where at given TF is
absolutely essential for function in one region, but is dispensable in other regions, serves as the foundational
observation for this R35 application. We will use other NFI- and Sox- family TF members that are universally
expressed in astrocytes to map region-specific transcriptional dependencies across the developing, adult, and
aging brain. Our analysis will be comprehensive, spanning core astrocyte functions, interactions with neurons,
and circuit-level activities. We posit that these region-specific transcriptional dependencies for astrocyte
function will provide an entry point for understanding how astrocyte diversity is encoded. Therefore, we will use
a host of transcriptomic, epigenomic, and proteomic approaches to uncover how these regional-specific TF
functions are conferred, while functionalizing roles for key downstream target genes. Finally, astrocyte
dysfunction is associated with a host of neurodegenerative diseases, including Alzheimer’s Disease. Here, we
will apply our findings and new mouse models to AD, seeking to uncover how these core features of astrocyte
TF function contribute to AD disease pathogenesis.

Public health relevance
Narrative The focal point of this project is to understand how transcription factors regulate the function of astrocytes and circuits in the brain and apply these findings to neurodegenerative diseases, including Alzheimer’s Disease. Given that astrocyte function is linked to a wide spectrum of neurological disease states, including Alzheimer’s and other neurodegenerative diseases, these studies are likely to reveal new mechanisms that can be applied to the understanding and possible treatment of these disorders. The transcription factor families we are studying NFI- and Sox- families, have been implicated in a host of neurological disorders, underscoring the direct connections between these studies and associated disease states.